Investigation of within-Latino heterogeneity in colorectal cancer mutational and T cell profiles

PROJECT SUMMARY
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as "NOT-CA-
24-032.” Racial and ethnic minority populations in the U.S., including the Hispanic/Latino/a/x/e (henceforth
referred to as Latino) community, are substantially underrepresented in cancer research. This creates missed
opportunities for investigating disparities and evaluating strategies to improve health equity. Importantly, the vast
heterogeneity in the Latino population with respect to genetic ancestry, sociodemographics, health behaviors,
and risk factors is often overlooked, leading to unaddressed health disparities across diverse Latino communities
(e.g. Mexican, Central/South American, Puerto Rican, Cuban). For example, in colorectal cancer (CRC),
evidence suggests that Puerto Rican and Cuban Latinos individuals may experience worse CRC mortality than
Mexican Latino and non-Hispanic white individuals, even after controlling for sociodemographic factors, stage
and access to care. To facilitate investigation of biological contributors to CRC disparities within the Latino
population, our team established the Latino Colorectal Cancer Consortium (LC3) in 2019. The parent award for
this proposal (R01CA248931) leverages LC3 data and biospecimens to uncover how ethnicity, genetic ancestry,
epidemiologic factors, and clinical variables independently influence immune responses to CRC. This is timely
and critical research as immunotherapy has been a paradigm-shifting strategy for saving lives, but it has not
worked in all people. We and others have shown the importance of tumor-associated T cell responses as positive
prognostic and predictive indicators, as well as substantial differences in immune “hot” tumors across racial and
ethnic populations. LC3 is a unique resource, but Puerto Rican and Cuban communities, the groups experiencing
the highest CRC mortality burden, need greater representation. To begin filling this gap, we launched a pilot
study using institutional funds at Cleveland Clinic. The Cleveland Clinic Latino Epidemiology (CCLE) Cohort,
which will become a sub-cohort of LC3, began accruing patients with CRC in northeast Ohio (Cleveland) and
southeast Florida (Weston), with all regulatory and operational details implemented as of February 2024 (i.e.
IRB approval, Spanish-speaking research coordinators, patient questionnaire, biospecimen collection). This
supplement will build upon institutional commitment for recruiting, collecting survey data, and obtaining germline
samples for 100 CCLE participants by permitting tumor somatic and immune landscape characterization on a
subset for comparisons across Latino groups, which cannot otherwise be supported. In Aim 1, we will integrate
demographic (e.g. age, sex, country of origin), social elements of health (e.g. area deprivation, BMI, physical
activity), and clinical (e.g. survival) data from CCLE participants into the LC3 pipeline. In Aim 2, we will obtain
and pathologically review tumor tissue from 50 of these CCLE participants. In Aim 3, we will compare T cell and
somatic mutational profiles from LC3 tumors, including CCLE, by country of origin and genetic ancestry. The
proposal is feasible in 1 year and will facilitate multi-level ethnic disparities research by the scientific community.

Public health relevance
PROJECT NARRATIVE This administrative supplement proposal seeks to expand the Latino Colorectal Cancer Consortium, a multi- institutional effort to build research infrastructure and study biological contributors to colorectal cancer disparities experienced in the U.S. Latino population by increasing representation from Latino individuals residing in the Midwest and southeast Florida. Evidence suggests that Puerto Rican and Cuban Latino individuals (prominent communities in these two regions) experience worse CRC mortality than Mexican Latino and non-Hispanic white individuals, and this study will permit examination of differences in immune responses that may impact these adverse clinical outcomes. This study will create an opportunity to study how within-group heterogeneity contributes to disparate CRC outcomes with novel molecular and epidemiologic data that will be expeditiously shared with the scientific community.